Dietary nutrient zeaxanthin enhances anti-tumor immunity by reprogramming CD8+ T cell function

PROJECT SUMMARY/ABSTRACT
While immunotherapy have benefited some cancer patients, a substantial proportion fails to respond.
Lifestyle choices have been increasingly recognized as a crucial aspect influencing the effectiveness of cancer
therapy. However, precise mechanisms through which lifestyle choices, especially diet, could impact patient
outcomes remain unclear. This is mainly due to the diversity of the dietary components involved.
To address this challenge, our lab compiled a proprietary blood nutrient library that provides a unique
collection of circulating nutrients to perform high-throughput, comprehensive cell-based screenings with
physiological relevance. Using our novel library, I conducted a co-culture screen to identify nutrient candidates
that enhance T cell-mediated tumor cytotoxicity. My preliminary data, for the first time, indicate that dietary
carotenoid zeaxanthin enhances T cell-mediated tumor cell killing in vitro and attenuates tumor growth potential
in C57BL/6 mice bearing B16F10 melanoma cells in a CD8+ T cell-dependent manner. This proposal will test the
central hypothesis that dietary nutrient zeaxanthin enhances anti-tumor immunity by reprogramming
CD8+ T cell function.
In Aim 1, I will demonstrate zeaxanthin’s translational potential with various preclinical models. I will
utilize tumor-bearing mice to further assess the anti-tumor effects of zeaxanthin in immunogenic and poorly
immunogenic models. I will evaluate zeaxanthin’s synergistic effect with immune checkpoint inhibitor therapy
such as anti-PD-1 antibody treatment. I will also characterize the changes in immune cell populations and
functional markers in tumors, spleens, and draining lymph nodes upon zeaxanthin administration.
In Aim 2, I will elucidate the precise molecular mechanisms underlying zeaxanthin’s effect on CD8+ T
cells using temporal, integrated mechanistic studies including kethoxal-assisted single-stranded DNA
sequencing (KAS-seq), phospho-kinase antibody array, and RNA sequencing. I will determine zeaxanthin’s
target in CD8+ T cells via in vitro knockdown and in vivo knockout models.
The Chen lab has a proven track record of expertise in demonstrating signaling significance of blood
chemicals with in-depth mechanistic studies and diverse mouse models. We foster close collaborations with Drs.
Justin Kline (UChicago) and Chuan He (HHMI & UChicago), who are experts in immuno-oncology and advanced
sequencing methods, respectively. Together, the support and resources available through this network provide
an ideal training and research platform to conduct the proposed project.
Overall, my proposal will employ cutting-edge approaches to demonstrate zeaxanthin’s impact on anti-
tumor immunity in vivo and to elucidate molecular mechanisms underlying zeaxanthin-dependent changes in
CD8+ T cell effector function. This proposal aims to gain insights on how lifestyle choices, particularly diet, impact
T-cell based cancer immunotherapy and to propose novel strategies to improve patient outcomes.

Public health relevance
PROJECT NARRATIVE While immunotherapy has shown remarkable success for some patients, an overall low patient response rate remains a critical challenge. This proposal is relevant to the NIH as it uncovers novel functions, targets, and molecular mechanisms of dietary nutrient zeaxanthin in enhancing anti-tumor immunity with diverse preclinical models and integrated, temporal mechanistic studies. This proposal endeavors to advance cancer research and improve patient outcomes by enhancing treatment strategies, offering additional treatment modalities, and highlighting the role of lifestyle choices in optimizing treatment outcomes.